IGF::OT::IGF

Quality Control / Quality Improvement Support for the Surveillance Research Project; The purpose of this contract is to obtain the services of a Contractor with experience in quality control of cancer data and surveillance systems. The Contractor’s expertise will complement the Surveillance Research Program (SRP) activities that are geared towards the population-based data collection, geospatial data systems, and quality improvement.